Deep learning for population genetics

Project Summary
With the introduction of whole-genome biobank-scale data, the last half decade has seen an explosion of
population genomic data but has left in its wake a gap in our ability to make sense of data of this magnitude.
Whereas population genetics as a field has been traditionally data-limited, the massive volume of current
sequencing means that previously unanswerable questions may now be within reach. To capitalize on this flood
of information we need new methods and modes of analysis.
Concurrently, the world of machine learning has been revolutionized by the rise of deep neural networks.
These so-called deep learning methods offer incredible flexibility as well as astounding improvements in
performance for a wide array of machine learning tasks, including computer vision, speech recognition, and
natural language processing. This proposal aims to harness the great potential of deep learning for population
genetic inference.
In recent years our group has made great strides in pioneering the use of deep learning for population
genomic analysis. The power of these methods for handling genetic data stems in part from their ability to
automatically learn to extract as much useful information as possible from an alignment of DNA sequences to
solve the task at hand, rather than relying on one or more predefined summary statistics which are generally
problem-specific and may omit key information present in the raw data. While that is so, the deep learning
methods that we and others have been developing are unable to scale to the sheer size of the data at hand,
particularly whole chromosome-scale data due to intrinsic limitations on the amount of computer memory needed
to process genotype matrices at this scale.
In this proposal we lay out the next phase of deep learning methods that need to be developed for our
computational methodology to keep pace with the glut of data being produced. In particular, we propose to design
deep neural networks that can compute directly on inferred ancestral recombination graphs (ARGs) rather than
genotype matrices, capitalizing on recent advances in graph learning and inference of ARGs from genetic data.
We plan to develop these networks into user-friendly software tools that will be shared with the community. We
will also investigate a variety of methods for estimating the uncertainty of predictions produced by deep learning
methods; this area is understudied in machine learning but of great importance to biological researchers who
require an accurate measure of the degree of uncertainty surrounding an estimate. Finally, we will bring self-
supervised learning techniques from generative artificial intelligence that have revolutionized science and society
at large, to bear in the world of population genetics. Together, these advances have the potential to transform
the methodological landscape of population genetic inference.

Public health relevance
Project Narrative Deep learning has revolutionized such disparate fields as computer vision, natural language processing, and speech recognition. In this proposal we aim to continue our work at bringing the power of deep learning into population genetic inference. We will design, implement, and apply novel deep learning methods and provide open source software for others to both use and build upon, thereby producing valuable tools for the genetics researchers at large.